Mitigating Racial/Ethnic and Socio-Economic Disparities in VA Care Quality and Patient Experience

Background/Rationale: Black-White disparities in control of hypertension and diabetes contribute to U.S.
racial disparities in life expectancy. Within VA, higher rates of uncontrolled hypertension or diabetes have been
identified in several racial/ethnic minority groups, compared with white Veterans. The extent to which socio-
economic status (SES)-related differences drive these racial-ethnic disparities is unknown. Patient Aligned
Care Teams (PACT) hold promise as a care delivery model to reduce disparities, however, implementation is
variable, particularly in sites with large proportions of minorities. Though traditional medical models cannot
directly change most social determinants of health like SES, facilities can adapt their delivery approaches to
better meet the needs and healthcare delivery preferences of their patients, e.g., incorporating evidence-based
interventions associated with improved hypertension or diabetes control in vulnerable groups, and in that way
influence outcomes indirectly. Appraisal of multi-level factors (healthcare system, site, patient) associated with
improved outcomes in vulnerable groups (racial/ethnic minorities and the lowest quintile SES), and elucidation
of implementation barriers, may inform VA strategies for tackling low quality and ameliorating high disparities.
Specific Aims:
Aim #1: Characterize associations between vulnerable group and quality (measured by intermediate clinical
outcome quality measures hypertension and diabetes control): (a) Determine variations by race/ethnicity and
SES in hypertension and diabetes care quality; (b) Examine SES as a mediator and moderator of the
relationship between race/ethnicity and quality; and (c) Identify multi-level predictors of quality and disparities.
Aim #2: Identify VA sites representing extremes in vulnerable group quality and disparities – high quality-low
disparity “positive deviant” sites, high disparity sites (high quality for majority groups, low quality for vulnerable
groups), and low performing sites (low quality for both majority and vulnerable groups) – and describe
characteristics of those sites.
Aim #3: Compare positive deviant, high disparity, and low performing sites: (a) Assess clinical practice delivery
arrangements for hypertension and diabetes care, particularly evidence-based approaches associated with
disparities reduction, and contextual factors identified in Aim #1; and (b) Identify barriers to and facilitators of
effective implementation of those delivery arrangements.
Methods: We propose a mixed-methods observational study using primary and secondary data sources to
achieve these aims. For Aims #1 and #2, we will use a national cohort of all Veterans using VA in fiscal year
2017, with their individual socio-demographics, diagnosed conditions, and residential characteristics linked with
existing data on VA site and healthcare system characteristics, including site-level PACT implementation and
healthcare system-level patient experience from VA quality metrics, and then linked to electronic quality
measures. We will determine site-specific performance for vulnerable and majority groups, and disparities
between these groups, then identify sites representing extreme examples of quality and disparities based on
decision rules applied to graphical displays of this data. For Aim #3, we will conduct key stakeholder interviews
at those sites, to explore local practices for achieving hypertension and diabetes control in their patients,
including barriers, facilitators, and contextual factors influencing implementation of evidence-based practices.
Anticipated Impacts on Veterans Health: This research will fill a knowledge gap about the prevalence of VA
disparities related to socio-economic vulnerability, provide evidence on clinical practice delivery arrangements
associated with higher quality and lower disparities for vulnerable groups, and provide effective field-tested
disparities-reduction approaches to inform evidence-based quality improvement initiatives and implementation
research to improve clinical outcomes for vulnerable groups at low-performing or high disparity VA sites.

Public health relevance
Narrative Within VA, among Veterans who have hypertension or diabetes, racial/ethnic minority Veterans are less likely than white Veterans to have these conditions under control. Some of the factors that can lead to poor control of these conditions may be related to the type of health care that the person receives, whereas other factors may be outside of the control of the health care system. Health care sites can sometimes deliver care in a way that will result in more patients achieving good control of their hypertension and diabetes. Our aims are to identify health care sites where there are fewer differences by race/ethnicity and by socio-economic status in the percentage of patients with good control of hypertension and diabetes, and to understand what some of the characteristics of patients, and their health care settings are that are associated with better control of these conditions.